Tau clearance and synaptic and cognitive function rescue by activation of mitochondrial clearance in tauopathy model

Summary:
Microtubule associated protein tau (MAPT) plays a major role in Alzheimer’s disease (AD) and
related disorder (ADRD) and have deleterious effects on mitochondrial and synaptic function and
neuroinflammation. Tau oligomers, prior to neurofibrillary tangle (NFT) formation, are toxic
species responsible for tau toxicity, mitochondrial and synaptic damage, and memory impairment.
However, the underlying mechanisms of abnormal tau accumulation and strategies to eliminate
them remain largely unknown. There is limited mechanistic study investigating the likely interplays
between mitochondrial dysfunction and neuroinflammation and their contribution to synaptic
damage and tauopathy in AD and related disorder (ADRD). PTEN-induced putative kinase 1
(PINK1) is important for the maintenance of mitochondrial integrity and quality control via
mitophgy. PINK1 was significantly decreased in AD-affected brains, AD mice, including widely
used tauopathy mice, suggesting defective mitophagy in AD and ADRD. Development and
validation of biological activity of PINK1 enhancer remains to be explored. This proposal will
address the fundamental unexplored questions of whether PINK1 is a key player in tau-related
aberrant mitochondria and synaptic injury and mitochondria-mediated neuroinflammation and
whether genetic and pharmacological enhancement of PINK1 proves beneficial for tau clearance,
mitochondrial quality control, and cognitive function as a potential therapeutic strategy in AD and
ADRD. We will elucidate PINK1-dependent new mechanisms underlying tau pathology and
clearance, proper mitochondrial and synaptic function via PINK1/mitochondria/neuroinflammation
axis relevant to the pathogenesis of neurodegeneration by employing PINK1 novel genetically
manipulated transgenic mouse models and pharmacological PINK1 enhancer in tau-rich
environment, and human neuronal cells containing patient AD- and non-AD-derived mitochondria.

Public health relevance
Narrative The aim of this project is to investigate a role of PTEN-induced putative kinase 1 (PINK1) in tau pathology and mitochondrial and synaptic stress, and neuroinflammation via PINK1- dependent mitochondrial clearance autophagy signaling, leading to neurodegeneration and cognitive decline relevant to the pathogenesis of Alzheimer’s disease and related disorders. The outcomes of the proposed studies would also support that PINK1 might be a potential new therapeutic agent for eliminating and limiting tau pathology and toxic tau species accumulation and restoring mitochondrial and synaptic function.